Social Determinants of Vision Health in Children

PROJECT SUMMARY
Amblyopia is the leading cause of vision loss in children. Delayed diagnosis and/or inadequate treatment of
amblyopia in early childhood may result in permanent vision loss. Children from historically marginalized
communities are at increased risk of preventable vision loss. However, the underlying social determinants of
health contributing to the racial, ethnic, and socioeconomic disparities in the visual outcomes of amblyopic
children are poorly understood. There is an urgent need to understand the factors contributing to diagnostic
delay and treatment failure in amblyopia – an effort that may offer novel opportunities for community-based
interventions and vision screening policies that promote health equity.
This proposal aims to investigate the delivery of preventive vision care in the US and develop tools to identify
children at risk of preventable vision loss. This research will leverage an array of large data sources – including
nationally representative surveys, insurance claims, and electronic health records – to identify modifiable factors
that may improve the visual outcomes of children with amblyopia from historically marginalized communities.
The central hypothesis is that household- and neighborhood-level social determinants of health influence the
receipt of vision screening (Aim 1), access to eye specialty care (Aim 2), and treatment success (Aim 3). The
investigations will evaluate existing vision screening policies in the US, identify geospatial barriers to health care
access, and help develop a prediction model to identify children at high risk for vision loss from amblyopia.
The candidate, Dr. Isdin Oke, is a pediatric ophthalmologist, data scientist, and health services researcher whose
long-term goal is to become an independent investigator with expertise in data-driven approaches to reduce
preventable vision loss in children. The career development plan will provide expertise in study design, research
methods, and advanced biostatistical approaches for conducting health equity research. The mentorship team
includes expertise in health services research, vision screening, social epidemiology, geospatial analyses, and
predictive modeling. The training environment at Boston Children's Hospital and Harvard Medical School
provides access to rich data sources and computational infrastructure. The unique combination of the training
plan, mentorship team, and institutional environment will accelerate the candidate's development into an NIH-
funded independent investigator and leader in data science and health disparities research in ophthalmology.

Public health relevance
PROJECT NARRATIVE Amblyopia is the leading cause of preventable vision loss among children in the United States. This project aims to identify vision screening policies that increase screening uptake, examine how factors influence access to eye specialty care, and develop predictive models to identify children with preventable vision loss. The findings will deepen our understanding of the social determinants of vision health in children and inform the development of novel interventions to improve visual outcomes for children nationwide.